Antiplatelet in Stroke: Safety and Effectiveness in Seniors (ASSESS)

The current U.S. and European guidelines recommend antiplatelet therapy such as aspirin, clopidogrel, or dual
antiplatelet therapy to reduce the risk of recurrent ischemic events in patients with noncardioembolic ischemic
stroke. However, selection of antiplatelet agents can be a difficult decision to make for older patients. Not only
older individuals are at increased risk for recurrent strokes, they also face risk for bleeding complications. While
it is known that drug selection should be individualized, it remains unknown how to tailor antiplatelet therapy
according to patient unique characteristics, preferences, needs, and values. The long-term goal is to use com-
parative effectiveness research to improve primary and secondary prevention in cardiovascular disease and
stroke. Leveraging the American Heart Association (AHA) Get With The Guidelines Stroke (GWTG) registry and
Medicare claims, the overall objective in this application is to develop patient-centered evidence-based strategies
to improve antiplatelet treatment selection for older individuals presenting with noncardioembolic ischemic stroke.
The central hypothesis is that individuals differ in many characteristics, such as age, sex, presence of comorbid-
ities, or concurrent medications, which can influence the potential benefits and harms associated with the treat-
ment. Once the variability in response to treatment is known, selection of an antiplatelet agent can be made
based on patient risk profiles, preferences, and known efficacy/safety of the agents, making treatment both safer
and more effective. Guided by strong preliminary data, this hypothesis will be tested by pursuing three specific
aims: 1) determine the long-term clinical effectiveness of different antiplatelet regimens in patients with noncar-
dioembolic ischemic stroke; 2) determine the long-term safety of different antiplatelet regimens; and 3) balance
benefits and harms of each antiplatelet regimen while incorporating patient preferences into decision-making.
The proposed research is innovative in four key ways: 1) a patient-centered approach is used to address a real-
life decisional dilemma facing stroke survivors and clinicians; 2) it shifts focus from selected samples in clinical
trials to nationwide representative stroke population, including traditionally underrepresented subgroups in com-
munity practice; 3) novel propensity score inverse probability weighting method using generalized boosted mod-
els (a machine learning technique) will be employed to mimic a trial-type multi-treatment design, uncover treat-
ment heterogeneity, and minimize selection bias in observational data; 4) beyond traditional mechanisms of
scientific publications, the evidence generated from this study will be disseminated to stroke survivors, clinicians,
and relevant stakeholders through the AHA GWTG-led national quality initiatives and patient-led efforts to insure
a rapid translation of seminal findings into clinical practice. The proposed research is significant, because it is
expected to help guide personalized antiplatelet therapy in older ischemic stroke survivors that could best meet
their needs and lead to better outcomes most meaningful to patients. Ultimately, such knowledge has the poten-
tial to inform evidence-based treatment decisions in stroke that now afflicts more than 7.2 million Americans.

Public health relevance
The proposed research will develop patient-centered evidence-based strategies to improve antiplatelet treatment selection for older individuals presenting with noncardioembolic ischemic stroke. It is relevant to public health because the development and adoption of personalized evidence-based antiplatelet therapy is expected to re- duce recurrent ischemic events, minimize treatment complications, and improve outcomes most meaningful to patients. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing funda- mental knowledge that will help to enhance health and reduce the burdens of illness and disability.